CLINICAL TRIAL OF NASAL CALCITONIN TO INCREASE BONE MINERAL DENSITY

The primary objective of this study is to determine whether treatment with nasal salmon calcitonin improves BMD in patients with AN.